The role of temporal prediction in guiding attention through time during language comprehension.

Project Summary/Abstract
Spoken language rapidly conveys information over time. Current theories hold that listeners make continuous
predictions about the importance and the timing of information as it arrives. Prior psycholinguistic studies have
investigated whether listeners pre-allocate attention to points in time when important information is predicted to
occur, but the results have not been consistent, and the underlying neurocognitive mechanisms remain
unclear. Non-linguistic studies of auditory and visual perception have shown that people use temporal
predictions to guide attention in time to behaviorally relevant events. This is achieved through two primary
mechanisms: rhythm-based and memory-based predictions. This proposal will take an interdisciplinary
approach, by investigating the role of these perceptual temporal attention mechanisms in language
comprehension through a psycholinguistic theoretical framework. Candidate sources of temporal prediction in
language are the rhythmic regularity of speech (the alternation of stressed and unstressed syllables) and
discourse cues (introduced by the linguistic context). This project will contribute to the lively contemporary
debate in speech neuroscience concerning the importance of neural entrainment, a mechanism of temporal
prediction. There are three specific aims: (1) Examine if rhythm-based temporal predictions arise from greater
rhythmic regularity in speech. (2) Determine whether memory-based temporal predictions are elicited by
discourse cues. (3) Elucidate the respective effects of speech rhythmic regularity and discourse cues on
semantic processing, a core component of language comprehension. Two experiments will employ
electrophysiological (EEG) measures of neural activity to characterize these mechanisms. The fellowship
applicant’s primary training goal is the acquisition of electrophysiological skills for cognitive neuroscience
research, including experimental design, data collection, analysis and interpretation. She will be supervised by
sponsors Drs. Mangun and Swaab, world leaders in the use of EEG methods to study attention and language,
respectively. Dr. Mangun is the Director of the UC Davis Center for Mind and Brain (CMB), an acclaimed hub
for research, methods development, and training using EEG to study cognition. The applicant will benefit from
the rich research and training environment at the CMB, including the NIMH-supported summer training
programs in electrophysiology (led by consultant Dr. Luck) and cognitive neuroscience (led by Dr. Mangun).
She will also be trained in computational modelling by the consultants Drs. Oganian and Breska during a 3-
month visit to Tübingen, Germany. This project will provide a better understanding of the role of temporal
prediction and attention in language comprehension, contributing to theoretical models and methodological
advancements in the cognitive neuroscience of language by reconciling diverging lines of research. Elucidating
the role of temporal prediction in language comprehension in healthy individuals is vital for understanding the
cognitive-neural bases of language disorders, which will inform the development of effective forms of therapy.

Public health relevance
Project Narrative As speech unfolds through time, listeners predict the importance and timing of incoming information. Several language disorders are associated with impairments in timing and attention mechanisms, yet the relevance of these mechanisms to language comprehension is not well defined. This project investigates the role of temporal prediction and attention in language processing for healthy individuals and will shape the development of effective forms of therapy for these disorders.